Quantitative and Functional Proteomics Core

The Quantitative and Functional Proteomics Core of the University of Washington Diabetes Research Center
provides affiliate investigators the powerful tools of modern mass spectrometry and complex data set analysis.
The goals of the Core are to: (1) Perform MS analyses for DRC affiliate investigators, such as quantifying
target analytes and obtaining spectra for structural identification of proteins; (2) Develop new MS methods for
structural identification or quantification of proteins involved in the pathogenesis of diabetes and its
complications, risk factors, or treatment.; (3) Assist DRC affiliates with experimental design of their studies to
ensure successful proteomics analysis and provide training in principles and use of MS; (4) Provide a central
facility for data storage, dissemination, and sharing; (5) Provide bioinformatics support for analyzing and
interpreting proteomic data sets and for integrating them with Gene Ontology, protein-protein interaction
databases, and pathway analysis; and (6) Provide bioinformatics support for integration of proteomic studies
with functional assays, with the long-term aim of providing an integrated, systems biology view of diabetes and
diabetes-related disease processes. By providing a centralized facility, the Core meets these goals with
optimal efficiency and cost-effectiveness, providing expertise necessary to perform state-of-the-art proteomics
and mass spectrometric studies at the cutting edge of current technology. Further, by centralizing and
standardizing procedures, the Quantitative and Functional Proteomics Core provides its affiliate investigators a
common set of analytical tools for obtaining a unified understanding of molecular mechanisms involved in
pathophysiologic processes of diabetes and its associated complications.